IGF::OT::IGF; FY14; PURPOSE: TO FUND THE BASE AWARD; OUTREACH AND EDUCATION TO HEALTH PROVIDERS ON SUBSTANCE USE; N01DA-14-1152; POP: 09/08/2014 - 09/07/2015.

Outreach and Education to Health Providers on Substance Use